2021 Tissue Repair and Regeneration GRC & GRS

Project Summary
Therapies that can promote tissue repair and regeneration will have immense impact on human and animal
health. Healthcare costs due to impaired tissue repair and regeneration following injury are a significant global
burden, and are projected to be in the tens of billions by 2023 [1]. The healthcare system is faced with ever
increasing numbers of non-healing chronic wounds, common in the elderly and in people with diabetes, as well
as other forms of impaired healing, such as scarring and fibrosis following traumatic injury. Scarring and fibrosis
can affect all organ systems including the skin, heart, lungs, liver and kidneys, and is common young, otherwise
healthy individuals. These types of pathological, dysregulated repair responses in the body affect millions of
people each year and demonstrate the critical need for new treatments and therapies to facilitate tissue repair
and regeneration. Therefore it is imperative that we understand the molecular and cellular mechanisms that
control repair and regeneration in vivo, and uncover the reasons why some organisms can regenerate while
others cannot. This is key in progressing regenerative medicine to a new level. Advances in regenerative
medicine occur through innovative research, and also through the rapid dissemination of breakthroughs in this
field through fostering communication and collaboration in the scientific community. The Gordon Research
Conference on Tissue Repair and Regeneration (GRC-TRR) has played an absolutely critical role in providing a
forum for communicating the latest discoveries and innovations for the past three decades.
The main objective of this conference is to bring together the top academic researchers with clinicians, early
career scientists and senior PIs, in order to spark and facilitate new ideas and to generate new collaborations
that will drive new discoveries and novel therapies in regenerative medicine. Specifically, we have planned nine
scientific sessions, ranging from basic science involving insights from model organisms and mathematical
modelling, to the more applied and clinical aspects, such as tissue engineering, the role of inflammation in tissue
destruction and healing, as well as the latest approaches in clinical treatments. This will bring novel insights into
how we can precisely manipulate tissues and organs in patients with developmental defects or injuries to provide
a regenerative outcome. The 2021 GRC-TRR, which convenes every other year, will be the 15th meeting of this
successful conference series. Programs for all of the past meetings can be found at the GRC website.

Public health relevance
Project Narrative This proposal seeks funding to support the KEY scientific conference in the world addressing tissue repair and regeneration, underpinning the most important medical focus of the future, combatting the debilitating effects of birth defects, trauma, surgery, chronic diseases, and, ultimately, ageing in all people. This meeting will bring together the world's premier scientists and clinicians to present and discuss their work, from basic mechanisms underlying tissue repair and regeneration, to clinical applications in human patients, as well as interact with and engage junior scientists and trainees who will be the next generation of innovators in this exciting and important field of biomedical science.